Establishing the clinical utility of sensorimotor adaptation for speech rehabilitation

Project Summary & Abstract
Individuals with brain injuries or disorders that affect movement (such as Parkinson’s disease, cerebral
palsy, amyotrophic lateral sclerosis, and many others) often have difficulties in being understood when they
speak. While treatments exist, they often require substantial conscious attention to the way speech is
produced, or require increased breath support to speak louder. Many individuals with speech disorders have
cognitive or respiratory difficulty that renders these treatments ineffective. These individuals will benefit from
alternative strategies that promote motor learning: the ability to alter motor actions through practice. One type
of motor learning, sensorimotor adaptation, is a particularly promising pathway for alternative rehabilitation. In
this paradigm, the auditory feedback people receive while speaking is externally perturbed, causing them to
quickly change their speech to oppose these perturbations. Because of its ability to rapidly induce changes in
speech production without conscious control, sensorimotor adaptation holds unique promise for rehabilitation.
However, its potential clinical applicability is limited by poor understanding of key clinically-relevant features.
First, existing sensorimotor adaptation paradigms do not affect speech in a way that facilitates
communication. To improve rehabilitation outcomes, sensorimotor learning must target clinically-relevant
speech parameters such as intelligibility. We address this barrier through a novel auditory perturbation that
artificially decreases the perceived space between vowels, causing speakers to produce more vowel contrast.
Critically, reduced vowel contrast is a hallmark of motor speech disorders and significantly contributes to
decreased intelligibility. We determine the effectiveness of this paradigm to increase intelligibility and test how
these increases are retained across multiple training sessions, how they generalize to untrained words, and
how they can be elicited in complex sentences—characteristics which are key for potential clinical applications.
Second, while sensorimotor adaptation is a robust effect on average, not all individuals learn to the
same degree. This variability limits the potential impact to only those who show a large degree of learning. This
proposal uses behavioral interventions and brain stimulation that target the hypothesized causes of this
variability. By directly manipulating these factors, we can determine, for the first time, the mechanisms that
underlie speech motor learning. Additionally, establishing how these factors can be modulated to increase
learning would allow treatment to benefit a wider range of individuals.
Although sensorimotor adaptation can quickly induce changes in speech, its current clinical applicability
is limited by substantial gaps in our understanding of its mechanisms. By establishing the capacity of
sensorimotor adaptation to increase speech intelligibility, characterizing retention and transfer of learning, and
identifying the mechanisms underlying variability between individuals, this work lays a critical foundation for
future treatments that optimize the clinical impact of motor learning.

Public health relevance
Project Narrative Communication and quality of life are greatly impaired by the loss of intelligibility that accompanies motor speech disorders such as Parkinson’s disease, cerebral palsy, and amyotrophic lateral sclerosis. The proposed studies refine a well-studied mechanism of speech learning, sensorimotor adaptation, to maximize its effects on intelligibility. By directly increasing vowel distinctiveness in speakers, and by characterising mechanisms underlying the variability, generalization, and retention of learning, this project takes the first steps to translate sensorimotor adaptation into a clinical tool for improving the efficacy of spoken communication.